TUMOR INHIBITORS AND RELATED SUBSTANCES

This proposal focuses on the synthesis of antineoplastic agents. In the quassinoid area major emphasis will be placed on completing syntheses of quassimarin, bruceantin, and glaucarubinone. As a result of the lower toxicity in in vivo systems of 4beta-hydroxy withanolide E relative to cardenolides and bufadienolides, a synthetic program centered around 4beta-hydroxy withanolide E has been initiated in an effort to uncover an analog possessing a reasonable therapeutic index. Part III of this proposal focuses on a convergent total synthesis of the potent cytotoxic cyclodepsidpeptide, jaspamide. In addition a number of analogs will be prepared in order to examine the structural requirements for biological activity.